Measuring functional similarity between transcriptional enhancers using deep learning

PROJECT SUMMARY Understanding transcriptional regulation remains as a major task in the molecular biology ﬁeld. Enhancers are genetic elements that regulate when and where genes are expressed and their expression levels. These elements are hard to discover because their locations and orientations are not constrained with respect to their target genes. Several diseases and susceptibility to certain diseases are linked to mutations and variants in enhancers. Multiple experimental and computational methods have been developed for locating enhancers. Computational methods are more suitable to handle the large number of genomes being sequenced now because they are faster, cheaper, and less labor intensive than experimental methods. Despite many available computational tools, we lack a sophisticated tool that can measure similarity in the enhancer activity of a pair of sequences. We propose here utilizing Deep Artiﬁcial Neural Networks (DANNs) to develop such a tool. The long-term objective of this project is to decipher the code governing gene regulation with the following speciﬁc aims: (i) design a computational tool for measuring enhancer-enhancer similarity, (ii) validate up to 96 putative enhancers experimentally, (iii) understand enhancer grammar, and (iv) annotate enhancers in more than 50 insect genomes. To achieve these aims, a novel application of DANNs is proposed. Current tools utilize DANNs to answer a yes-no question: does a sequence have similar activity to the tissue-speciﬁc enhancers comprising a particular training set of known enhancers? These approaches require training a separate network on each tissue, leading to inconsistent performances on different tissues. Instead, here we use a DANN to answer a related but different question: does this sequence have similar enhancer activity to a single known tissue-speciﬁc enhancer? This deep network should perform consistently on different cell types because it is trained on pairs of sequences — not individual sequences as is the case in the available tools — representing all tissues for which there are known enhancers. The DANN is trained to recognize sequence pairs with similar enhancer activities and those with dissimilar activities including (i) two enhancers active in two different tissues, (ii) one enhancer and a random genomic sequence, and (iii) two random genomic sequences. The tool outputs a score between 0 and 1, indicating how similar the enhancer activities of the two sequences are. Using a much simpler machine learning algorithm than DANNs, we demonstrate that pairs with similar enhancer activities can be separated from pairs of random genomic sequences or pairs of one enhancer and a random genomic sequence with a very high accuracy. The new tool has many important potential applications including consistent annotation of enhancers across cell types and related species. Our tool can annotate enhancers active in a cell type that has a small number of known enhancers, and it can annotate enhancers in related genomes when there is a set of known enhancers demarcated in one of them. Discovering new transcription factor binding sites is another potential application. Studying enhancer “design principles” and the effects of variants can be facilitated using the proposed tool. Such applications will advance our ﬁeld.

Public health relevance
PROJECT NARRATIVE An enhancer is a genetic element that controls when and in which cell type a gene is expressed as well as the expression level. Mutations and variants in enhancers are linked to a number of diseases — including cancer — and may increase the risk of developing certain diseases. We will apply machine learning (a branch of artiﬁcial intelligence) and experimental approaches to developing an advanced computational tool that measures the similarity in enhancer activity between two DNA regions, facilitating the discovery of enhancers and their study.